Integrating Machine Learning and Atomistic Simulations for Accurate Prediction of Drug Molecular Crystal Solubility

Project Summary / Abstract
Solubility is a crucial factor in pharmaceutical drug discovery and development, directly
impacting bioavailability, efficacy, and formulation. However, experimental solubility assays are
often complex and resource-intensive, while informatics-based approaches are hindered by the
lack of comprehensive, high-quality datasets. Atomistic simulations, though promising, are
limited by inadequate interatomic potentials, challenges in free energy estimation, and the
polymorphism of molecular crystals.
Our lab focuses on designing and applying atomistic simulations, statistical mechanics, and
machine learning methods to predict the properties of materials and molecules. Our long-term
vision is to create a computational platform that transforms drug discovery by enabling reliable
predictions of key molecular properties. Over the next five years, we will develop a robust and
automatable computational framework to predict the solubility of drug-related molecular crystals.
This effort will involve creating efficient machine learning potentials (MLPs) based on quantum
mechanical calculations, designed for broad applicability to organic systems of biological
relevance. We will leverage these MLPs, along with generative models, to enhance crystal
structure predictions. We will also build an automated workflow for high-throughput solubility
computations across a diverse set of molecular systems under consistent conditions.
Additionally, we will develop data-driven models that improve the accuracy of informatics-based
solubility predictions.
The computational framework will be validated against publicly available solubility datasets and
further tested using blinded solubility data for newly synthesized compounds. This will
demonstrate the accuracy and utility of the framework in real-world drug discovery contexts.

Public health relevance
Project Narrative The goal of this research is to develop a cutting-edge computational and machine learning framework for predicting the solubility of drug-related molecular crystals, a key factor influencing bioavailability and therapeutic efficacy. This framework will significantly improve the drug development process by reducing the failure rate of drug candidates due to solubility issues. Ultimately, this will help streamline the pipeline, lower development costs, and accelerate the time-to-market for new therapies.